Optimizing Keratinocyte Calcium Signaling Enhances Differentiation in Aged Epidermis

Aged epidermis shows progressive defects in proliferation, differentiation and barrier formation, manifesting as
eczematous dermatoses, xerosis, itch and increased susceptibility to contact dermatitis and infections.
Previously, we found that defects in epidermal calcium signaling, transduced through the plasma membrane
calcium receptor (CaSR), underlie intrinsic aging. In preliminary findings we show that CaSR expression
decreases in aged epidermis and CaSR agonists rescue calcium signaling, E-cadherin reorganization, growth
and migration in aged keratinocytes, epidermal equivalents and aged or CaSR-/- mice. Because burn pit
pollution also causes premature skin aging (extrinsic skin aging) and is a focus of veteran health, we propose
to determine what age-related transcriptional or epigenetic mechanisms drive intrinsic vs. extrinsic aging. We
next will assess how increasing CaSR expression or function, using exogenous vitamin D or CaSR agonists,
rescue intrinsic or extrinsic age-related epidermal defects. Finally, we will use these results to develop
therapeutic approaches that ameliorate calcium signaling and differentiation/barrier defects in intrinsically aged
mice or mice whose skin is prematurely aged due to particulate pollution.
The overall hypothesis of this project is that the age-related decreases in calcium signaling dysregulate
intrinsic and extrinsic keratinocyte differentiation and barrier homeostasis.
The overall goal of this project is to normalize age-related epidermal defects by enhancing calcium signaling
and CaSR expression/function.

Public health relevance
As veterans age, their skin increasingly develops eczema, dry skin, itch and increased susceptibility to contact dermatitis/infections. These diagnoses are an increasingly large proportion of aged veteran patient visits. In a survey of aged veterans, 38% reported itch. Similar skin problems are seen in younger patients with premature extrinsic skin aging due to particulate skin pollution, a problem made more relevant by newly described disease in veterans exposed to burn pit fumes. Decreases in the plasma membrane calcium receptor are to blame for many of these defects, particularly in veterans in the 70-90 age range. We aim to figure out why the plasma membrane calcium receptor is decreased in aged veteran skin and skin cells. We will use agents that stimulate this receptor to fix age-related growth and barrier defects. We will test these agents and find optimal treatments to improve skin dryness, itch and susceptibility to contact dermatitis. The overall goal here is to normalize age-related epidermal defects, thereby relieving age-related skin conditions common to veterans.